Regulation of Osteoclastogenesis and Inflammatory Osteolysis

Project Summary/Abstract
Osteoclasts (OCs), the bone resorbing cells, arise from myeloid OC progenitors (OCPs) and are critical
for bone remodeling and homeostasis. OC differentiation and activity are tightly regulated by intrinsic negative
feedback loops (autoregulatory) and by paracrine factors secreted by other cells, most notably osteoprotegerin.
Intrinsic regulators are critically important for calibrating physiologic OCgenesis, disruption of which leads to
uncontrolled pathologic OCgenesis and osteolysis. Using proteomic studies in an independent study, we have
recently identified a novel autoregulatory role of IFN stimulated gene-15 (ISG15), a ubiquitin-like small molecule,
in OCgenesis. Specifically, we found that RANKL induces expression of ISG15 in OCPs and OCs, which binds
to NEMO (a.k.a. IKKg) to down regulates NF-kB signaling. We found that stimulation of OCPs with RANKL
induces IFNa/b secretion by OCPs, which engages and activates type 1 IFN receptor (IFNAR) signaling in OCPs
themselves to trigger ISG15-dependent local autoregulatory negative feedback loop to limit the extent of
OCgenesis. This mechanism appears to depend on STimulator of INterferon Genes (STING), which we find to
be expressed in response to RANKL and is essential for IFNa/b, and ISG15 expression, and was validated by
data showing that blocking either STING or IFNa/b diminishes RANKL-induced ISG15 levels and exacerbates
OCgenesis. Collectively, these observations suggest that endogenous ISG15 inhibits OCgenesis through its
classical binding to target proteins, which is facilitated by the sequential action of highly specific E1 (Ube1L), E2
(UbcH8), E3 (Herc6) ligases, a post-translational modification termed ISGylation that maintains cellular
homeostasis. However, ISGylation is a reversible mechanism, whereby under inflammatory conditions, free
ISG15 is generated in abundance by cells, secreted to the extracellular (EC) space by secretory vesicles, and
acts as a cytokine by binding LFA1 receptor. In this regard, we show that inflammatory stimulation of OCPs with
the bacterial product LPS inhibits expression of Ube1L, the E1 enzyme, and induces secretion of ample ECISG15.
More surprisingly, we found that ISG15KO mice responded poorly to LPS and developed negligible osteolysis
compared to robust bone loss by LPS-induced WT counterparts. This event was TNF-dependent, evident by low
levels of TNFa in ISG15KO serum compared to copious amounts of TNF in serum of WT mice. Hence, ECISG15
appears to exacerbate OCgenesis and depends on intact endogenous ISG15.
Based on these observations, our overarching hypothesis states that ISG15 has bi-modal functions: under
physiologic conditions, ISG15 is conjugated to OC signaling proteins to limit OCgenesis and maintain
homeostasis, whereas inflammatory conditions facilitate secretion of free ECISG15, which then acts as an
inflammatory cytokine to exacerbate OCgenesis and osteolysis. To test this hypothesis, we will: (1) Elucidate
the mechanism by which intracellular ISG15 inhibits OCs, and (2) Determine the mechanism(s) by which
ECISG15 exacerbates basal OCgenesis and inflammatory osteolysis

Public health relevance
Project Narrative We identified endogenous IFN-Stimulated Gene 15 (ISG15) as a negative regulator of osteoclasts, whereas cell-secreted ISG15 mediates inflammatory osteolysis. The goal of the project is to elucidate the respective mechanisms and develop strategies to combat osteolysis using modified forms of ISG15 as a therapy.